Handoffs and Transitions in Critical Care - Understanding Scalability

PROJECT SUMMARY: “Handoffs and Transitions in Critical Care – Acute care Implementation Research Ethics (HATRICC-AIRE)” There is an urgent need to characterize implementation strategies suitable for use in the fast-paced, high stakes environment of critical care, a setting that is underrepresented in the implementation science literature. At the same time, such research must be conducted in an ethical fashion, one that respects the rights of research subjects. Investigators and research ethics boards face recurrent difficulties evaluating ethics in implementation research, which presents issues that have not been clearly or comprehensively addressed in prominent medical ethical guidelines. For example, it is frequently unclear whether the health professionals targeted by implementation studies should be considered “research subjects,” whether and how they should give informed consent, and which gatekeepers can appropriately give permission for institutions to participate in implementation trials. Healthcare professionals are meanwhile exposed to a number of potential risks by implementation research, including sanction for certain care practices, altered relationships with colleagues, altered relationships with patients and families, interruptions to clinical workflow, and retaliation for deciding to opt out of an implementation study. In this project, we use qualitative methods to unmask and explore challenges to the ethical conduct of implementation research in acute care settings. We will elicit the perspectives of diverse stakeholders in acute care implementation research, including clinicians and other frontline employees, clinical and administrative leaders, and institutional review board members. We will then refine current research ethics frameworks to more closely address the unique challenges raised by implementation research. The proximate goal of this work is to facilitate the hybrid effectiveness-implementation study supported by the parent grant. The longer-term goal is to guide the ethical conduct of implementation research by developing a framework that can be employed in future studies based in acute care. The findings of this study will be disseminated in the scientific literature to facilitate widespread use. The potential public health impact of this work is significant because the resulting ethical framework will meaningfully augment investigators’ ability to conduct ethical, rigorous acute care implementation research aimed at narrowing the evidence-to-practice gap. This project is specific to bioethics research; it is relevant to the NIH’s interest in bioethical issues in research including the interface of clinical research and clinical care in the learning health system and methods for obtaining and documenting informed consent. It is also relevant to the NHLBI’s interest in bioethical questions related to implementation science research.

Public health relevance
PROJECT NARRATIVE: “Handoffs and Transitions in Critical Care – Acute care Implementation Research Ethics (HATRICC-US)” There exists a critical gap in knowledge about the ethical conduct of implementation research in acute care settings. This project seeks to elucidate ethical challenges to implementation research in the acute care setting by characterizing the perspectives of three groups of stakeholders: clinicians, clinical and administrative leaders, and institutional review board members. The deliverable from this project is an ethical framework to guide the conduct of implementation in acute care research, a framework that balances human subjects protections with the practicalities of conducting research with many potential participants.